GLYCEMIC INDEX OF MIXED MEALS

The glycemic response to food (glycemic index) has been utilized in diabetic diets in the past but this can be altered by other foods consumed during a meal. The investigators will examine the inter and intra- individual variability of the glycemic index of mixed meals (GIMM) in both diabetic and non-diabetic individuals. These results will allow diabetics to improve glycemic control by arranging daily menus using standard meals with established glycemic responses. Progress report and summary of findings: During this period of time, six additional subjects underwent this study. Coefficient of variation of GIMM appears to be approximately 30% for diabetics and 12% for non- diabetics. The estimated intraclass correlation coefficient is approximately 0.9 for diabetics and 0.7 for controls. The investigators are continuing recruitment of patients.